CD90-targeted nanoparticles for in vivo hematopoietic stem cell gene therapy

PROJECT SUMMARY/ABSTRACT
Patients with genetic blood diseases and disorders are commonly treated with blood (hematopoietic) stem cell
(HSC) transplants from healthy, human leukocyte antigen (HLA)-matched sibling donors. Unfortunately, for most
patients, there is no HLA-identical sibling donor available, and transplantation of HSCs from alternative donors
can lead to life-threatening complications such as graft-vs-host disease (GVHD). To avoid severe side effects,
especially from GVHD, correcting the patient's own HSCs—a process called gene therapy—has become a
promising alternative treatment approach for genetic diseases and disorders affecting the blood. Despite
significant progress in the field of HSC gene therapy, currently available treatment strategies are greatly limited
by the requirement of highly sophisticated infrastructure in specialized facilities similar to bone marrow
transplantations limiting the accessibility of this treatment option for low- and middle-income countries. The main
bottleneck is the current inability to safely and efficiently perform HSC gene therapy directly in the patient
(in vivo). The ability to genetically modify HSCs in vivo would 1) improve the feasibility of HSC gene therapy, 2)
enable portable gene therapy, and 3) avoid expensive infrastructure. With the aim to refine the target for HSC
gene therapy, we recently performed comprehensive studies in our nonhuman primate (NHP) stem cell
transplantation and gene therapy model. This study identified a highly HSC-enriched cell population that
contained all required cells for rapid short-term recovery and robust long-term multilineage engraftment of gene-
modified cells providing the ideal target for in vivo gene therapy. Most importantly, we recently reported highly
efficient encapsulation of gene-editing nucleases into polymeric and lipid nanoparticles (NPs). NPs can be
surface modified for targeting, lyophilized for enhanced portability, and have been successfully used in vivo.
Here, we hypothesize that targeting our novel HSC-enriched phenotype in vivo performing injections of NPs
directly into the bone marrow stem cell compartment will allow us to overcome current limitations in HSC gene
therapy. In Aim 1, we will optimize our NP formulations that can be loaded with next-generation double-strand
break independent gene-editing agents and functionalize the surface for targeting. Untargeted as well as
targeted NPs will be tested in vitro on cell lines and primary human HSCs for efficiency and specificity. In Aim 2,
we will evaluate different versions of NP in the humanized mouse model to determine the biodistribution after
intraosseous injections, on-target specificity, and long-term efficiency in vivo. Finally, in Aim 3 we will focus on
the scale-up and clinical translation using our preclinical NHP large animal model. We will perform short-term
studies to evaluate the biodistribution and safety profile of intramarrow NP injections, long-term studies to monitor
persistence of editing, as well as in vivo selection to increase the frequency of gene editing.

Public health relevance
PROJECT NARRATIVE Blood stem cell gene therapy for the treatment of blood diseases and disorders is currently greatly limited by the targeting efficiency and the number of institutions with appropriate infrastructure to perform this treatment. The ability to safely and specifically modify blood stem cells directly in patients (in vivo) would help to increase the feasibility and portability of gene therapy. Here, we aim to develop polymeric and lipid nanoparticle formulations to perform gene editing in vivo and increase efficiency, reduce costs, and bring gene therapy to the patient.